Identification of therapeutic molecules to treat amphetamine use disorders using our DNA-encoded library (DEL) technology

PROJECT SUMMARY
Identification of therapeutic molecules to treat amphetamine use disorders using our DNA-encoded
library (DEL) technology
The objective of this Phase I SBIR project is to utilize our own innovative and proprietary DEL drug discovery
platform to identify drug-like compounds binding the orphan receptor GPR37, a member of the G-protein
coupled receptors (GPCRs) family. The overreaching goal is to restore brain functions linked to the reward
system without impacting harmful neurotransmitter systems. Amphetamine effects are primarily mediated
through dopaminergic pathways. We have extensively studied these pathways, and the basal ganglia signaling
in general, in the Greengard lab. Amphetamines disrupt the mesocorticolimbic dopaminergic system, which
plays a key role for reward, dependence and withdrawal. Amphetamine-dependency is linked to altered cAMP
levels, affecting broad cAMP signaling. PKA and MAPK/ERK pathways involved in gene expression and
synaptic plasticity are also activated. GPCRs constitute a crucial therapeutic category; those lacking a known
ligand are called orphan GPCRs or oGPCRs. We have identified several oGPCRs selectively expressed in
brain regions highly relevant to amphetamine use disorders and regulating the pathways above mentioned.
Our proposal aims to focus on GPR37, which, according to our expertise and initial findings, emerges as the
strongest candidate to potentially restore equilibrium to basal ganglia signaling. High-throughput screening
(HTS) drug discovery is hindered by the requirement for large quantities of protein target, often obtained from
E. coli and synonymous of non-physiological conditions. These and other HTS limitations are deleterious for
GPCRs. Our research strategy aims to overcome these limitations by using a DNA-encoded library (DEL)
screening approach that allows small amounts of protein to be used while retaining very large screening power
(125 million compounds) and an assay that is activity-independent. The hypothesis is that the extensive pool of
compounds, coupled with their inherent diversity, will enable the efficient and cost-effective identification of
high-affinity binders for GPR37. Quantities of receptor used for DEL screening are compatible with mammalian
cells. These measures will guarantee the utilization of a physiological GPR37 receptor, enhancing the
reliability. Aim 1 will focus on the production of GPR37 in mammalian cells, followed by its purification and
immobilization. This material will also be used for validation steps proposed in Aim 2. Aim 1 DEL screening
will involve the testing of 125 million DEL compounds, utilizing either purified GPR37 or GPR37-containing
membranes as the target source. Aim 1 aims to generate a list of 100 preferred hits, which we will then
prioritize for further validation. Aim 2 will involve the chemical synthesis of 100 on-DNA compounds and 18 off-
DNA. Each hit will be validated for binding by 2 methods, followed by activity assessment in mammalian cells.
The program aims to identify and validate compounds with a KD in the three-digit nanomolar range or lower,
and demonstrating receptor activity. This achievement will serve as a robust proof of concept, fully validating
Phase I and providing a solid foundation for initiating Phase II with 5 compounds.

Public health relevance
Project narrative: Substance use disorders (SUDs), like amphetamine use disorders, stem from disruptions in brain signaling pathways affecting the reward system, with notable impacts on G-protein coupled receptors (GPCRs), a key therapeutic category in FDA-approved medications. Among these, approximately 85 understudied orphan GPCRs (oGPCRs) present promising targets for restoring impaired brain pathways crucial for SUDs, particularly those interacting with the dopaminergic system. This Phase I SBIR proposal aims to validate the effectiveness of DNA- encoded library (DEL) technology in identifying high-affinity compounds, offering a novel approach to rectify chronic amphetamine-induced brain signaling abnormalities and potentially advance treatments for SUDs.